Hazmat Disaster Preparedness Training Program

Atlantic Center for Occupational Health and Safety Training
HDPTP Abstract
The Atlantic Center for Occupational Health and Safety Training has a long history of effective training that meets the
requirements of OSHA 29CFR1910.120, providing hazardous materials knowledge and skills to over 506,000 workers since
1987. Our Center will train workers about safety issues during emergencies and disasters. Our Center has effectively trained
workers and volunteers to respond safely to disasters including Ebola, Hurricanes, and other national disasters. The courses
develop competency in workers to critically analyze dangerous situations, and enable them to identify safe work practices. Key
principals of adult education are incorporated into our training, and training courses are developed to include peer-learning,
hands-on activities, and development critical thinking skills. The Center has a robust evaluation plan, and will continue to
expand the types of date collected on impact of training on workplace practice, as well as how training can more effectively
influence workplace safety culture. The Center proposes to expand our efforts by including the Northeast New York COSH
(NENYCOSH) to provide training in the NY State Capital (Albany) Region.
The HDPT program enhances the safety and health of current hazardous materials workers and chemical responders by
delivering training to workers responding to disaster. These courses focus on prevention and preparedness so that disaster
response personnel are aware of safety and health hazards and mitigation techniques before they initiate a disaster response.
The Center will also adapt and develop training to address emerging issues, such as resiliency, climate change, and opioids as
they impact worker health and safety. Over the next five years, the Center proposes to train 9,335 workers in 560 courses
resulting in 76,416 contact hours in the HDPTP.